Peer Behavioral Activation Utilization to Address Structural Racism and Discrimination and Improve HIV Outcomes in High-Risk, Substance-Using Populations- PUSH

Background. Substance use continues to be a major driver of HIV acquisition and has been associated with
suboptimal ART adherence, treatment interruption, and inability to achieve or maintain viral suppression.1 Use
of PrEP, a key tool for HIV prevention, is disproportionately lower in racial/ethnic minorities, as well as people
who inject drugs. Factors related to structural racism and discrimination (SRD) may contribute to low rates of
adherence in these populations.2 New long-acting injectable (LAI) formulations of PrEP/ART provide a potential
biomedical intervention to overcome adherence challenges, however, due to the prolonged subtherapeutic
period after LAI discontinuation, ensuring adherence is crucial. A peer-delivered reinforcement-based
intervention may be a promising solution for improving LAI adherence. Our team has developed through several
rounds of stakeholder feedback a peer-delivered behavioral activation and problem-solving intervention, Peer
Activate. Peer Activate focuses on problem-solving skills to improve adherence to ART and/or PrEP both at the
individual level and social/structural barriers to care (i.e., transportation, housing) and includes behavioral
activation to promote engagement in rewarding, substance-free activities in one's environment and structured
daily activities to promote treatment adherence. Delivery by a peer with formal training and shared lived
experiences enhances the impact of the intervention on SRD-related factors. However, Peer Activate has not
been evaluated in the context of LAI PrEP/ART. Preliminary Studies. This proposal builds upon our team's
prior studies demonstrating 1) our ability to engage patients with and at risk for HIV, facing multiple barriers due
to SRD, and provide LAI PrEP/ART in community-based settings; 2) the feasibility and acceptability of Peer
Activate and promise in improving HIV treatment adherence for people who use substances.; and 3) promise for
cost-effectiveness. Approach. We propose a randomized Type 1 hybrid effectiveness-implementation trial
(N=186) to test the effectiveness and implementation of Peer Activate for LAI PrEP/ART (“Peer Activate-LAI”)
vs. enhanced treatment as usual for a predominantly Black substance using population living with or at high risk
for HIV, evaluating the following over 12 months: (1) effectiveness: a) LAI PrEP/ART adherence (primary; receipt
of all 6 maintenance injections within 7-day window); b) substance use (secondary; urine toxicology, self-report);
c) SRD as moderators of effectiveness (exploratory); (2) Implementation of Peer Activate-LAI including
feasibility, acceptability, fidelity, and adoption guided by RE-AIM and Proctor's model,9,10 assessed using mixed
methods, including a rapid ethnographic assessment of how SRD-related factors may affect implementation;
and (3) Economic viability of Peer Activate-LAI, including cost of implementation and sustainment and cost-
effectiveness from multiple stakeholder perspectives. Implications. This study will inform a potentially scalable,
cost-effective model for facilitating effective adherence to LAI formulations of ART/PrEP within Black, substance
using populations who to date have had limited support for improving LAI adherence for HIV ART/PrEP.

Public health relevance
Project Narrative Low-income, racial/ethnic minoritized individuals with substance use disorder (SUD) face the greatest disparities in HIV treatment and prevention outcomes, including experiencing significant barriers due to structural factors, including racism and discrimination. Although long acting injectable (LAI) formulations of HIV treatment and prevention are being developed to reduce barriers to care, additional adherence support is still needed. Implementing an evidence-based, peer delivered approach to support adherence to LAI interventions may be a feasible, acceptable, and sustainable way to improve HIV treatment and prevention outcomes among underserved, minority individuals with SUD.